CORE--FLOW CYTOMETRY FACILITY

To provide participants in the lymphocyte biology program project with complete flow cytometry and digital imaging microscopy services. This will include sorting and analyses of immunofluorescence (up to 5 colors), for ward and narrow-angle light scatter, cell diameter (axial pulse width), membrane potential, cell cycle, and intracellular free calcium levels. Digital imaging microscopy offers the capability to analyze [Ca2+]I oscillatory behavior and subcellular localization of makers with three dimensional reconstruction.